Delaware INBRE

Project Summary
The Delaware IDeA Network of Biomedical Research Excellence (DE-INBRE) catalyzes multidisciplinary
biomedical research initiatives that build Delaware’s biomedical research capacity and workforce. The DE-
INBRE network consists of five network partner institutions (NPIs): The University of Delaware, a Carnegie R1-
doctoral intensive- very high research activity university which also has three associate-in-arts campuses,
leads the DE-INBRE program in partnership with two minority-serving primarily undergraduate institutions
(PUIs), Delaware State University (DSU) and Delaware Technical Community College, along with two medical
institutions, Christiana Care Health System and Nemours Children’s Health-Delaware. DE-INBRE’s
Administrative (ADMIN) core provides logistic/administrative support to all DE-INBRE activities while ensuring
compliance with all federal, state and institutional policies, administers a robust Student Research Program
that provides mentored scientific research internships to Delaware’s undergraduates, a comprehensive set of
Professional Development workshops that foster the success of scientists ranging from undergraduates
through faculty, and an Evaluation program that ensures that all DE-INBRE programs are contributing to its
mission. The Data Science core supports computational resources, access to biomedical datasets, data
science consulting, and the development/dissemination of workshops that train investigators in data science
methodology. The Renovation component supports the physical infrastructure needed for DSU to establish at
Data Science Laboratory to foster expansion of Data Science research at this HBCU. The DRPP program
administers a research grant program that provides seed funding to Delaware’s early stage and new
investigators to launch successful biomedical research careers. The Centralized Shared Resources core
ensures that Delaware’s scientific community has ready access to a network of 20 core facilities located across
Delaware by supporting policies that keep core access open to investigators at all NPIs, vouchers to support
investigator core use, training of core facility staff in core management and new technologies. All DE-INBRE
components synergize into a robust initiative that will make a major impact on Delaware’s research community.

Public health relevance
Project narrative Delaware INBRE build’s Delaware’s capacity to do biomedical research by supporting investigator driven research projects, undergraduate research training, student/faculty professional development and research infrastructure. This ensures that all Delawareans have access to the training needed to pursue biomedical research careers while discovering new knowledge that can be applied to improve the health of the Nation.